Characterizing the Molecular Mechanisms of PRSS56-Dependent Ocular Growth and Refractive Error

Abstract
Refractive errors are a major cause of vision loss worldwide, and the rising prevalence of myopia and
associated blinding conditions is a significant public health concern. Regulation of ocular axial growth is critical
for normal refractive development to ensure that a focused image falls directly on the retina. Our goal is to
decode the molecular and genetic program that governs ocular axial growth. Ocular growth is driven by an
intrinsic, genetic process during prenatal and postnatal development (vision-unadjusted) and by a postnatal,
vision-guided process, emmetropization, thought to interact with intrinsic ocular growth such that the eye's
axial length matches its optical power. Enhanced intrinsic ocular growth and defective emmetropization are
thought to cause a mismatch between ocular axial length and optical power, leading to myopia. Ocular axial
growth relies on signals from the retina to the sclera to promote extracellular matrix remodeling and ocular
elongation. However, the mechanisms by which the signals translate to ocular axial growth remain elusive. Our
studies suggest that PRSS56, a secreted serine protease, is a component of the intrinsic machinery that
supports ocular axial growth. However, it is not known whether Prss56 has a direct role in emmetropization.
We propose to uncover the molecular and cellular processes underlying PRSS56-dependent refractive
development and associated errors and assess the role of PRSS56 in vision-guided ocular growth.
Despite evidence that altered expression of PRSS56 affects ocular axial length, the factors that regulate its
expression and mediate its effect are not known. The Wnt-mediated pathway is associated with myopia
pathogenesis, and we have found that Prss56 responds to Wnt signaling agonists. In Aim 1, we will elucidate
the link between Wnt and Prss56 by modulating WNT activity in genetic mouse models and studying the effect
on the retinal expression of PRSS56 and ocular growth (Aim 1.1). We will also determine, in conditional mouse
models, whether retinal pigment epithelium–localized Serpine3—which we identified as a candidate mediator
of PRSS56-dependent growth—helps relay PRSS56-dependent signals that support ocular growth (Aim 1.2).
In Aim 2, we will characterize the function of PRSS56 to guide the identification of its substrate(s) and targeted
therapies. In Aim 3, we will test the role of PRSS56 in emmetropization and PRSS56-dependent regulation of
ocular axial growth by temporarily inactivating PRSS56 in conditional mutant mice and using experimental
paradigms that induce axial elongation in response to visual blur or optical defocus.
The proposed studies will provide a molecular and genetic framework to understand the mechanisms of ocular
growth and guide us to potential therapeutic targets to manage myopia.

Public health relevance
PROJECT NARRATIVE The modern rise in myopia has received a lot of attention and is of a major concern because myopic individuals with abnormally elongated eye are at risk of developing irreversible blinding diseases including retinal detachment, macular degeneration, and glaucoma. Thus, there is an urgent unmet public health need for interventions aimed at controlling abnormal growth of the eye and thereby, preventing or slowing progression of myopia. We will utilize myopic animal models to determine factors that control eye's growth, which will guide us to identify new therapeutic targets to manage myopia.